Equipment Supplement for Discovery of Pharmacogenomic Biomarkers for OATP1B1 and OATP1B3

The abstract of the funded parent award is contained in the 2 page Research Strategy attachment required
under NOT-GM-22-017. (See Research Strategy Section).

Public health relevance
See Research Strategy Section for Project Narrative.